HIGHLY PARALLEL ANALYSIS OF 5' AND 3' UTR VARIANTS IN NEURODEVELOPMENTAL DISORDERS

ABSTRACT
Substantial investments are being made to sequence the genomes of families with autism and other
neurodevelopmental disorders (NDD). However, identifying disease mutations outside the ~1% of protein
coding sequences is challenging because 1) the ‘search space’ is much larger, and thus many more mutations
occur by chance, and 2) there is no simple code to identify deleterious mutations in non-coding sequences,
and thus loss of function mutations must be defined experimentally. In addition, the consequences of mutations
in non-coding (i.e. regulatory) sequences are often highly dependent on the specific cell type. Thus, functional
assays must be conducted in vivo, in the appropriate CNS cell types.
To address the search space challenge, we have focused specifically on the untranslated regions (UTRs)
of mRNAs. UTRs are important, conserved regulatory sequences that profoundly impact protein levels by
altering translation rates or transcript stability for specific genes. To address the lack of a code for interpreting
UTR mutations, we have developed a unique combination of expertise to conduct massively parallel
functional analysis of UTR variants from NDD patients, in relevant cell types in the brain. Combining
two innovative but established components: massively parallel reporter assays, and cell type specific
translational profiling, we aim to establish a pipeline to 1) Identify UTR mutations that result in altered protein
levels, 2) conduct genetic burden and association testing on these variants, and 3) train machine learning
models that can predict the effects of future mutations in developing neurons of the brain. This project will
leverage the existing large investment in NDD genome sequencing by defining individual non-coding, disease-
causing mutations in a class of sequences that has, so far, not been the focus of disease studies.

Public health relevance
NARRATIVE A significant fraction of cases of neurodevelopmental disorders (NDD) are caused by coding mutations that prematurely terminate the translation of specific RNAs into proteins. However, protein production can also be disrupted by mutations in the untranslated regions (UTRs) of RNAs. We propose to detect and analyze new NDD mutations by bringing to bear a unique set of tools specifically designed to study translational regulation by UTRs, extending the utility of ongoing efforts to sequence the genomes of tens of thousands of NDD cases across the US and the world.